Career-Enhancement

The Career Enhancement Core (CEC) will oversee the educational and career enhancement activities of the
UCDC. The overarching goal of the CEC is to train the next-generation of rare diseases researchers. The main
aim of the CEC is to recruit, train, and retain trainees and faculty at different career stages and provide resources
to facilitate a career in rare diseases research, specifically in urea cycle disorders (UCD) and other inborn errors
of metabolism. Additionally, the CEC will also build on its previous accomplishments and enhance a curriculum
that will be beneficial for career enhancement of early-stage investigators not only in the UCDC, but across all
other consortia of the RDCRN.
CEC Program Overview, Application, Review, and Selection Process
The CEC has predoctoral and postdoctoral/junior faculty components. The predoctoral component focuses on
clinical and research training of medical students, graduate students, genetic counselors, and neuropsychology
trainees by didactics and involvement in data-mining and clinical projects of the UCDC. Postdoctoral and junior
faculty career enhancement will focus on funding protected research time, mentoring on a specific UCD research
project, and assisting in the transition to an independent research career. Applications will consist of a 5-page
research proposal, statement of relevance of proposal to UCDC mission, career development plan, and letters
of support from the mentor and the sponsoring Institution. Applications will be scored using NIH scoring system
by a “study section” consisting of the CEC leadership, UCDC investigators and NIH PO/SO. The award will be
for one year; depending upon the progress and the impact of the work, trainees will be considered for a second
year of funding. Special focus will be paid to recruit women and individuals from underrepresented minorities.
Oversight and Evaluation
The accomplishments of the specific aims of the candidate will be monitored frequently so that any barriers or
difficulties, whether programmatic or personal, can be identified and addressed early. The progress of the trainee
will be assessed by primary research mentor, presentations at the monthly UCDC phone meetings, and quarterly
meetings with the CEC PI (Dr. Nagamani). Awardees present at the annual UCDC conference and submit a
written progress report at the end of the funding.
Through the activities of the CEC, the UCDC hopes to build on its already outstanding record of training
successful next-generation of researchers in rare diseases.